Simplifying the description, not the system: Advanced ecological theory for real-world microbiomes

Project summary
Microbial ecosystems play a major role in human health. An ability to quantitatively predict their function and
dynamics, and design communities with desired properties, would be transformative for microbiome-based
diagnostics and treatments of diseases. However, natural systems are highly complex, harboring hundreds of
species. Recently, an important theoretical development was the realization that high-diversity ecosystems are
subject to different emergent laws, arising from diversity. These emergent behaviors limit our ability to obtain
generalizable insight from simplified examples in the lab. Understanding the behavior and properties of
complex communities requires ecological theory and computational tools specific to the high-diversity regime,
considering microbiomes in their natural complex context.
The solution is to simplify the description, not the system. Recent advancements in my group have
demonstrated that increasing community diversity can enhance the predictive power of simple ecological
models, a phenomenon we refer to as “emergent simplicity.” This breaks from traditional perspectives, opening
the door to new methodologies that work because of diversity, not despite it. Over the next five years, my
group will: (1) Build computational tools to identify functionally significant taxa groupings, applicable to diverse
ecosystems like marine, soil, and gut microbiomes; (2) Create statistical methods to design microbial
communities with desired functions, with initial validations focused on synthetic communities suppressing
pathogens such as K. pneumoniae; (3) Test the power and limitations of coarse-grained modeling in a complex
natural community (soil); and (4) Systematize the insights from these empirical examples into a theory of
ecosystem coarse-graining, classifying ecosystem properties by their “coarse-grainability,” and guiding data
collection by identifying the most informative perturbations for predictive coarse models to be learned.
The research will yield (A) statistical and computational tools of broad applicability to fundamental biology,
such as de novo discovery of relevant dynamical variables; (B) new statistical methodologies to discover
bacterial interactions from community-level observations; and (C) a systematic methodology for developing
interpretable coarse-grained models trainable on minimal data, enabling prediction in clinical contexts where
obtaining millions of training examples is infeasible.

Public health relevance
Project Narrative This research program will develop new theoretical and computational tools for ecology and microbiology. These tools will allow scientists to better predict the behavior of complex communities of microbes, such as those in the human gut; and to decipher the mechanisms by which the collective action of many species gives rise to desired community properties, such as providing better resistance to a disease-causing pathogen.